Urinary biomarkers for prostate cancer diagnosis and risk assessment

PROJECT ABSTRACT
This project aims to develop a urine-based screening tool for prostate cancer that could affect at
least 13 million men in the US who receive prostate cancer screening every year. Today, serum
prostate specific antigen (PSA) remains the most commonly used screening test for prostate
cancer (PCa), but the lack of specificity of PSA has led to unnecessary prostate biopsies. In
addition, PCa is a heterogeneous disease ranging from indolent to life threatening or clinically
significant. About 20% to 50% of men who get a positive biopsy have PCa that never grows,
spreads, or harms them. Thus, there is a great need to develop better alternatives that can
reliably diagnose PCa and also identify men with clinically significant prostate cancer who are
most likely to benefit from early diagnosis while avoiding the over-diagnosis and overtreatment of
indolent cancer. Research has found that trained dogs can distinguish patients with and without
PCa by sniffing their urine. In turn, we can use these odor-producing volatile organic compounds
(VOCs) as biomarkers for PCa diagnosis and risk assessment. Our preliminary data have shown
that VOCs in urine are significantly different (p<0.05) between prostate cancer patients and
healthy subjects. We hypothesize that pathological processes of PCa can alter the production of
specific VOCs that are different and distinguishable from the VOC profile of healthy individuals.
We also hypothesize that certain PCa specific VOCs are conserved across different ethnic
groups, and that these VOCs are highly significant for diagnosing PCa. In this proposed study, we
aim to (1) develop a urinary VOC-based screening model for PCa diagnosis; (2) create a
prostate cancer risk model based on urinary VOCs for differentiating indolent from clinically
significant PCa, and (3) evaluate longitudinal patterns of change of urinary VOC profiles in men
with and without prostate disease. The expected outcomes and impacts of the project is to
develop a non-invasive urinary VOC based model that can detect PCa with over 90 % accuracy,
thus providing a better alternative to the current PSA test for PCa diagnosis. Furthermore, the
VOC risk model could become a revolutionary tool with high specificity for clinically significant
PCa; it has the benefit of early diagnosis while preventing over-diagnosis (i.e. finding indolent
PCa that will never develop into advanced deleterious PCa) and overtreatment of indolent PCa
(i.e. getting unnecessary and aggressive treatment). It would directly benefit over 13 million men
receiving PSA testing in the US annually, and prevent at least 2 million unnecessary biopsies and
their inherent risks (pain, bleeding, infection, death), and will reduce cost (time away from work,
cost of procedure and ancillary studies) and anxiety.

Public health relevance
PROJECT NARRATIVES This research is to use the organic metabolites in urine as biomarkers to diagnose prostate cancer (PCa). We expect to develop a non-invasive urinary VOC based screening model that can detect PCa with over 90 % accuracy, thus providing a better alternative to the current PSA test for PCa diagnosis. We will also develop a VOC risk model could become a revolutionary tool with high specificity for clinically significant PCa to provide the benefit of early diagnosis while preventing over-diagnosis (i.e. finding indolent PCa that will never develop into advanced deleterious PCa) and overtreatment (i.e. getting unnecessary and aggressive treatment) of indolent PCa.